The Wingless Transduction Pathway in Synapse Development

DESCRIPTION (provided by applicant): The long-term goal of this project is to elucidate the signaling mechanisms underlying activity-dependent synapse formation. We have demonstrated that the secreted glycoprotein Wingless (Wg/Wnt-1), best known for its crucial role in early morphogenesis and pattern formation, is also a fundamental organizer of glutamatergic synapses in the fruit fly Drosophila. Our current studies implicate Wnts in rapid, activity-dependent, structural and functional synaptic modifications. In humans, misregulation of Wnt signaling is associated with a number of cognitive disorders, such as schizophrenia, bipolar disorder, and Alzheimer's disease. Therefore, understanding the mechanisms of Wnt signaling in the nervous system will have important implications for our ability to design clinical strategies to treat these diseases. In this project our experimental approach makes extensive use of live imaging, including that of completely intact animals, combined with electron microscopy, molecular genetics, and electrophysiology to investigate the mechanisms by which activity induces the secretion of Wg and promotes new synaptic formation. We will also explore the synaptic role of Evenless Interrupted/ Wntless/Sprint, a multipass transmembrane protein recently discovered to be critical in epithelial Wg secretion. In particular we will (1) determine the role of electrical activity in Wg synthesis, trafficking and release, (2) determine the significance and molecular mechanisms of activity and Wg-dependent synaptic plasticity, and (3) determine the role of Evi at synapses and test the hypothesis that at the NMJ Evi mediates novel trans-synaptic signaling. We expect our findings will bring about important insights into the general nature of synapse plasticity, as these fly synapses show a considerable degree of molecular conservation with mammalian central synapses, and as Wnts are also involved in mammalian systems during synapse differentiation and long-term modifications in synaptic function.

Public health relevance
NARRATIVE An important characteristic of neuronal circuits is their ability to change, a property generally referred to as synaptic plasticity, which lies at the foundation of important processes such as learning and memory. Studies in both vertebrates and invertebrates have identified a signaling mechanism, mediated by the secreted protein Wnt/Wingless, which plays key roles in synaptic plasticity. In humans, misregulation of Wnt signaling is associated with a number of cognitive disorders, such as schizophrenia, bipolar disorder, and Alzheimer's disease. Therefore, understanding the mechanisms of Wnt signaling in the nervous system will have important implications for our ability to design clinical strategies to treat these diseases. The goal of this project is to use the powerful genetic approaches available for fruit flies to elucidate the function of Wnts in synaptic plasticity. Specifically in this project we will: (1) determine how synaptic activity induces the trafficking and secretion of Wnt to synapses, (2) investigate how Wnt induces synaptic plasticity, and (3), explore the function of a protein which is hypothesized as being involved in the transport of Wnt across the synapse.